Innate immune receptor driven programmed necrosis is coupled to hyper-synthesis of inflammatory lipid mediators in host defense

PROJECT SUMMARY
Inflammatory responses organized by innate immune cells are critical to defend against infectious insult and
initiate healing responses to injury. Mechanisms that tether the strength of the inflammatory response to the
magnitude of the threat are equally important to limit unnecessarily damaging aspects of the innate immune
response. Inflammatory modes of programmed cell death such as necroptosis are a critical last line of cell
intrinsic defense to remove infected and irreparable cells while simultaneously creating and expanding an
inflammatory state in remaining healthy tissues. How inflammatory modes of death such as necroptosis create
inflammation is important to understand as it not only provides insight into the roles of necroptosis in defense
against specific pathogens, but also helps to identify therapeutic targets that can be pharmaceutically
leveraged to inhibit out of control inflammation in disease states typified by unregulated necroptotic death. We
have identified a new regulatory circuit by which the necroptotic cell death pathway is coupled to the
hyperproduction and release of inflammatory lipid mediators. The active synthesis of inflammatory lipids during
necroptotic death critically requires the activity of RIP kinase 3 and may impinge upon specific phospho-
lipases. We hypothesize that this linkage of cell death and lipid metabolism can significantly shape
inflammatory responses in vitro and in vivo. In AIM 1 we will define the mechanism by which canonical
necroptotic signals govern hyper-lipid production in primary immune cells. In AIM2 we will explore the
implications of this phenomena for necroptosis associated inflammation.

Public health relevance
PROJECT NARRATIVE When host white blood cells, called macrophages, are infected or injured, a series of signals may cause the macrophage to commit a form of cellular “suicide” called necroptosis. This cell suicide can promote a response of the human immune system called inflammation. We have discovered a new means by which necroptosis suicide may cause inflammation in the body by causing the dying cell to produce molecules called lipids which drive inflammation.